Illuminating the spatial and temporal diversity of the gastrointestinal microbial ecosystem with label-free nonlinear optical microscopy

PROJECT SUMMARY/ABSTRACT
Inflammatory Bowel Disease (IBD) is a chronic gastrointestinal condition that affects an estimated 2.4-3.1
million people in the US. IBD is increasing in prevalence and cost, and linked to the development of colorectal
cancer. While recent progress has improved our understanding of IBD pathophysiology, many unknowns
remain about the relationship between host and microbe interactions in the intestinal microenvironment. A
stronger understanding of the microscopic biochemical basis of IBD could lead more effective prevention and
treatment. Established technologies lack the ability to observe bacteria and host cells with sufficient temporal
and spatial resolution, with most methods performing a bulk analysis ex vivo. Many established imaging
methods do not have sufficient spatial resolution to observe bacteria cells, and established super-resolution
imaging methods are not well-suited for dynamic imaging in vivo. IBD is one of many driving forces that has led
to a critical need for new methods to observe and quantify the intestinal microenvironment with high spatial and
temporal resolution.
This proposal seeks to address this need by developing and testing a novel optical imaging technology to
observe the dynamics and heterogeneity of host-microbe interactions in the live mouse intestinal
microenvironment. A new method for multiphoton super-resolution microscopy will be developed, compatible
with label-free autofluorescence imaging of NAD(P)H, FAD, and tryptophan, all of which are essential to host
and microbe metabolism in the intestine. Furthermore, this method will be used for super-resolution imaging of
label-free biochemical information with hyperspectral coherent Raman scattering microscopy and structural
information with sum-frequency generation of collagen. In order to accelerate the acquisition of 5D data with
temporal and spectral information (x-y-z-t-λ), computational methods will be employed to acquire and save only
the essential information, enabling imaging fast dynamics and large volumes of data. These newly established
methods will be used to image and characterize the microenvironment of the large intestines of mice in vivo,
examining differences between IBD and control mice, and metabolic changes associated with different grades
of IBD. This project fulfills a critical need for new approaches to study the metabolism of the intestinal
microenvironment in vivo with unprecedented spatial and temporal resolution. While focused on IBD, this
technology has broad potential for studying other complex tissue microenvironments, and will be especially
useful for bringing the next generation of microscopy methods to microbiology.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease (IBD) is one of many conditions where the microbiome plays an essential, but poorly-understood, role, stemming from the lack of available tools to study the live microbiome. This project will develop novel methods to improve the spatial and temporal resolution of label-free nonlinear optical microscopy, enabling simultaneous imaging of host and microbe cells in the intestinal microenvironment in mice in vivo with metabolic, biochemical, and structural contrast. This work will shed light on the microscopic biochemical basis for IBD and open the door for studying complicated microenvironments with high spatial and temporal resolution.